Heterogeneity of protein corona (PC) composition using highly sensitive magnetic levitation (MagLev) system

ABSTRACT
The evolution of PC (layer of proteins/biomolecules that adsorbs at the surface of NPs upon contact by
biological fluids) in vivo still remains highly challenging due to the complexity of human physiology, the complex
nature of the biomolecules adsorbs on the surface, which is one of the main barriers of clinical translation of
nanomaterials. The ex vivo approaches for preparation of PC on the surface of the model NPs do not provide
homogenous corona formation as commonly perceived in the literature and the composition of the PC varies
even across identical NPs with the same sizes in the same batch and using the same biological fluid. The current
available PC characterizations or isolation techniques are not able to detect small variations in the composition
of the PC and heterogeneity of the PC structure. Therefore, non-specific extraction and pool analysis of the PC
in ex vivo condition may cause error and/or misinterpretation of the PC outcomes which significantly influence
the clinical translation of NPs. We show in the preliminary data that although the standard MagLev systems are
able to separate PC coated and uncoated NPs however, it is not able to discriminate among PC coated NPs
with various PC composition at the surface of the NPs due their very similar density and low resolution of the
standard MagLev systems. In this exploratory research we aim to develop a higher sensitivity MagLev system
to show the heterogeneity and variation of PC composition on the surface of the NPs, a critical ignored factor in
clinical translation of nanomaterials and failures of nanomedicine. In such highly sensitive MagLev configuration,
the resolution enhances 1 to 3 orders of magnitude (compared with sensitivity of standard MagLev system (i.e.,
10-3 g/cm3)) which is high enough to separate PC coated NPs with different PC coverages/compositions (e.g.,
number and type of the proteins at the surface) and very slight differences in the density (ranging from 0.001
g/cm3 to 0.00001 g/cm3 which is not detectable using standard MagLev system). Our preliminary data using a
prototype high sensitivity MagLev system as proof-of-concept, confirms that how identical objects (i.e.,
commercial identical nylon particles) with the same density and levitation heights in the standard MagLev system
have significant different levitation heights in a high sensitivity (prototype) MagLev system indicating low
resolution of the standard of the MagLev systems to detect such small variations/changes. The current state-of-
the-art in this type of separation is that there are simple proofs-of-concept of many of its foundational concepts,
but little use of fully developed methods by biologists and clinicians. This project will both solidify the fundamental
biophysical science of MagLev as a simple analytical tool in biochemistry and provide demonstrations of uses
for nanomedicine applications.

Public health relevance
NARRATIVE Current approaches do not have enough resolution to distinguish the heterogeneity of the identical NPs’ PC composition. In this study we aim to develop a highly sensitive MagLev system to probe the small variations in the PC composition of the same identical NPs in terms of number and/or type of the proteins.